Stratification of Cancer Risk in Patients with Non-Dysplastic Barrett's Esophagus using TissueCypher: The SCRiBE study

Project Summary
Barrett’s esophagus (BE), the condition in which an abnormal columnar mucosa replaces esophageal
squamous mucosa damaged by gastroesophageal reflux disease (GERD), is the only known precursor of
esophageal adenocarcinoma (EAC), a deadly cancer whose incidence has increased more than eight-fold over
the past 50 years. During this time, our primary strategy for preventing EAC deaths has remained essentially
unchanged - using endoscopy to screen GERD patients for BE, and enrolling BE patients in a program of
endoscopic surveillance. This stagnant strategy has failed to stem the rising frequency of EAC because current
screening practices are inadequate, and because surveillance relies on finding dysplasia, a biomarker with
considerable shortcomings, to trigger a cancer-preventive intervention. New screening tests are available that
could profoundly increase identification of BE patients, but it makes little sense to expand screening efforts
merely to enter more patients into expensive, ineffective surveillance programs. The TissueCypher BE Assay,
which can detect precancerous molecular and cellular changes in BE biopsies without dysplasia, has the
potential to be a precision risk-stratification test that could change the practice paradigm for BE patients.
Retrospective, case-control studies, heavily enriched with patients who developed dysplasia and EAC, have
shown that TissueCypher can identify BE patients at high and low risk for neoplastic progression. However, if
TissueCypher is to be used clinically for risk stratification, then the promising results of these studies in a
“cherry-picked” population of BE patients will need validation in a general population of patients with non-
dysplastic BE (NDBE). Ideally, validation would be in the form of a randomized, controlled trial (RCT), but the
large sample size and lengthy follow-up durations required for such a study on NDBE have been deemed
untenable. Our proposed study utilizes an alternative, innovative design to assess TissueCypher’s predictive
performance accurately without the untenable requirements of an RCT. We will use biopsy specimens already
available in a large community GI practice to establish an unbiased study cohort of 2,000 consecutive patients
who had baseline endoscopies with biopsies showing NDBE in 2008-2011, and who had ≥1 follow-up
endoscopies performed up to December 2021. TissueCypher will be run on baseline biopsy specimens, and
we will assess its performance in predicting neoplastic progression as identified in subsequent endoscopic
biopsies. We also will determine if TissueCypher’s predictive performance can be improved by incorporating
clinical variables and enhanced image analysis features. Validation of TissueCypher’s ability to risk-stratify BE
patients could shift the BE clinical practice paradigm from one of expensive and ineffective endoscopic
surveillance to one of precision medicine test-guided management with early intervention for high-risk patients
and reduced surveillance for low-risk patients. This would justify expanding BE screening efforts, and could
stem the rising frequency of EAC in a cost-effective manner.

Public health relevance
Project Narrative Over the past 50 years, there has been an eight-fold increase in the frequency of esophageal adenocarcinoma (EAC), a deadly tumor that develops in patients who have gastroesophageal reflux disease (GERD) complicated by a change in the lining of the esophagus called Barrett’s esophagus (BE). The current policy of using endoscopy to identify individuals with GERD symptoms who have BE, and then enrolling BE patients in a program of regular endoscopy to detect pre-cancerous changes has failed to stem the rising frequency of EAC, largely because of the lack of a reliable test to identify which BE patients are at high risk for cancer development. Preliminary studies suggest that a new precision medicine test called TissueCypher can identify BE patients at high risk for cancer development, and the proposed study is designed to validate TissueCypher’s utility as a BE risk-stratification tool, a finding of high relevance to public health that could stem the rising frequency of EAC.